M/C INVESTIGATION OF NTM MYCOBACTERIA IN PATIENTS WITH CYSTIC FIBROSIS

Clinical investigation to determine the impact of nontuberculous mycobacteria on the natural course of cystic fibrosis lung disease in the United States Cystic Fibrosis centers.